Pathogenesis in Segmental Demyelination

Project Summary
Abstract: Segmental demyelination is a pathologic process of stripping off the myelin sheath, which shunts
current out of axons and results in the failure of action potential propagation in a variety of peripheral nerve
diseases. However, the molecular program that leads to the demyelination remains unclear, which hampers
the therapeutic development for demyelinating neuropathies. Humans with autosomal recessive mutations in
FIG4 gene develop Charcot-Marie-Tooth disease type-4J (CMT4J), a disease characterized by segmental
demyelination. Our preliminary studies in a CMT4J mouse model (Fig4−/−) have demonstrated that segmental
demyelination is associated with increased intracellular Ca2+ in myelinating Schwann cells and macrophages
accumulation in the spinal roots. Administering a Ca2+ chelator suppresses the demyelination in Fig4−/− mice.
Therefore, this mouse becomes an excellent model to investigate the molecular events underlying
demyelination. Toward this end, we will test our central hypothesis that signals from FIG4-deficient axons
and/or macrophages exacerbate the overload of intracellular Ca2+ in FIG4-deficient Schwann cells, leading to
segmental demyelination. We propose three Specific Aims: (1) FIG4-deficient Schwann cells are sensitized to
demyelinate upon challenge with Ca2+; (2) FIG4-deficient macrophages release cytokine IL12B that triggers
further increases in intracellular Ca2+ in FIG4-deficient Schwann cells, leading to demyelination; (3) Individual
proteins in the PAS complex have different roles in the development and maintenance of myelin and axons.
These studies will have the potential to uncover novel molecular mechanisms underlying demyelinating
peripheral neuropathies and identify targets for therapeutic development.

Public health relevance
Project Narrative Segmental demyelination in patients with CMT4J disease is a prominent pathological features as well as in other demyelinating neuropathies. This proposal will study novel molecular pathways for segmental demyelination. Identified molecular targets could be utilized to develop therapy against demyelination.